Glycan regulation of fetomaternal tolerance

PROJECT SUMMARY/ABSTRACT
A central question in reproductive immunology is how the fetus and placenta avoid being rejected by the
maternal immune system. Despite the substantial progress made on this question in recent years, many key
knowledge gaps remain. These gaps not only prevent us from leveraging underlying mechanisms to induce
antigen-specific immune tolerance in the clinical arena, but also limit investigation into the pathogenesis of
intrauterine growth restriction, spontaneous abortion, preeclampsia, and preterm labor, i.e., pregnancy
complications that may all involve aberrant activation of the maternal immune system to placental antigens.
Recently, our laboratory has described key roles for B cell-mediated antigen presentation and antigen
glycosylation in suppressing immune responses to placental antigens in mice. Specifically, we found that a
surrogate model antigen expressed by trophoblasts (t-mOVA) is presented to maternal CD4 T cells exclusively
by antigen-specific B cells, and that these B cells are suppressed through the actions of t-mOVA’s heavily
sialylated N-linked glycans, thus in turn suppressing the CD4 T cells. This major new line of investigation raises
immediate questions that we address in this proposal. Specifically, Aim 1 will use both mouse (t-mOVA) and
human models to evaluate the hypothesis that glycan-specific IgM natural antibodies bind to antigens shed
from the placenta, activating complement and thus causing the antigens to accumulate on follicular dendritic
cells in the spleen. This accumulation in turn allows the antigens’ glycans to suppress antigen-specific B cells.
Substantiation of this pathway would suggest new ways to conceptualize the pathogenesis of human
pregnancy complications such as preeclampsia that are linked to increased antibody and complement
deposition on trophoblast membranes. Aim 2 then seeks to the determine the features of trophoblast glycans
that impart them with immunosuppressive properties, which, together with Aim 1, would inform how best to
harness trophoblast glycobiology for therapeutic purposes. It will employ a variety of techniques including mass
spectrometry to define the structures of t-mOVA’s glycans, and will fingerprint the glycans that decorate human
syncytiotrophoblast brush border membrane proteins bathed in maternal blood. Lastly, Aim 3 will address the
behavior of the tissue resident memory T cells that populate the decidua. These cells are positioned to defend
against congenital infection but also pose potential direct threats to fetal survival. Using mouse models, it will
determine the responsiveness of the cells to trophoblast antigens, as well as whether they are suppressed by
trophoblast antigen-associated glycans, like B and T cells are systemically. Together, we expect this work to
have a major impact on the field as it begins to connect the discovery that glycans play a central role in
fetomaternal tolerance with other critical questions in reproductive immunology and obstetrics. The work will
also further a second long-term goal of the fetomaternal tolerance field, namely, to foster application of
underlying mechanisms to immune tolerance induction in the clinical arena.

Public health relevance
PROJECT NARRATIVE The unresolved question of how the fetus and placenta avoid being rejected by the maternal immune system has major implications for understanding potential disorders of human pregnancy such as spontaneous abortion and preeclampsia. Capitalizing on recent work demonstrating the potent immune-modulatory function of the carbohydrate structures that decorate placental proteins, this proposal seeks to gain insight into how these structures suppress maternal immune responses both systemically and locally, within the pregnant uterus. We anticipate our work will also foster application of underlying mechanisms to immune tolerance induction in the clinical arena.